Cognitive Development Society 2001 Meeting

DESCRIPTION (provided by applicant): The inaugural meeting of the Cognitive Development Society took place in Chapel Hill, NC, October 8-9, 1999. The 270 + participants included senior researchers and graduate students from the US and abroad who are interested in the study of cognitive development. The present request is for funds to support their second meeting, to be held October 26-27, 2001 in Virginia Beach, VA. The goal of the meeting is to enhance scientific progress in their understanding of cognitive development by updating researchers' awareness of new developments in the field, fostering debate on relevant topics, teaching new methodological and statistical skills, and encouraging broad applications to the health, education, and welfare of children and adolescents. The meeting will include plenary addresses and break-out groups organized as symposia and workshops, and open poster sessions to encourage participation by all attendees at the meeting. The program will be approximately one-half invited and one-half submitted, with a Program Committee in charge of issuing invitations and selecting among submissions.